Role of the CX3CL1 C-terminus in reversing age-dependent Alzheimers neurodegeneration

ABSTRACT
Alzheimer's disease (AD) is the most common age-dependent neurodegenerative disease. How neurons
are lost in AD brains remains contested, although many studies have postulated that toxic β-amyloid peptide
(Aβ) in various forms (such as soluble multimers or oligomers) as well as tau aggregates contribute to neuronal
loss in aging AD brains and synaptic dysfunction in AD patients. AD mouse models such as PS19 and 5XFAD
do develop age-dependent neurogeneration, supporting the above assertion. Currently, AD therapy is centered
on developing drugs to block or remove amyloid deposition or tau aggregation. In this proposal, we aim to
investigate how to revert neuronal loss in AD brains as an alternative therapeutic strategy by reversing
degenerative processes. We have recently discovered that mice overexpressing either full-length CX3CL1
(Tg-CX3CL1) or the C-terminal domain of CX3CL1 (Tg-CX3CL1-ct) show enhanced neurogenesis.
CX3CL1, which is also known as fractalkine, is a type I transmembrane chemokine (Bazan et al., 1997;Pan et
al., 1997) and is cleaved by ADAM10 (Hurst et al., 2012;Hundhausen et al., 2003) to release its N-terminal
fragment containing the C-XXX-C motif, which mediates binding to the G protein-coupled CX3CR1 receptor (Imai
et al., 1997). Since the discovery of CX3CL1, its biological functions have exclusively been shown to occur
through CX3CL1/CX3CR1 interactions, which activate signal transduction to regulate inflammatory responses,
leukocyte capture and infiltration, as well as other immune functions. However, we have discovered that the C-
terminal domain has a back-signaling function, which regulates the expression of genes important for cell growth
or differentiation. We aim to test the hypothesis that neuronal expression of CX3CL1 enhances
neurogenesis through its C-terminal domain, which replenishes neuronal loss and fosters recovery of
synaptic functions in AD mouse models. Three specific aims are proposed to test this hypothesis: Aim 1: To
determine the role of CX3CL1 C-terminal domain (CX3CL1-ct) in the control of neurogenesis; Aim 2: To enhance
neurogenesis to reverse impaired synaptic functions in AD mouse models; and Aim 3: To explore potential
therapeutic use of CX3CL1-ct in age-dependent neurogenesis for AD therapy. Accomplishing the experiments
as proposed will provide novel answers as to the translational potential of CX3CL1 in AD treatment. Knowledge
gained from this study will guide future development of molecules targeted as an AD combinatorial therapy that
will not only reducing amyloid deposition or tau aggregation, but will also replenish neurons.

Public health relevance
Project Narrative Alzheimer's disease (AD) is the most common age-dependent neurodegenerative disease and AD pathogenesis results in progressive development of amyloid plaques, neurofibrillary tangles, and neuronal loss. Neuronal loss is particularly an age-associated event, which inevitably leads to loss of synapses and increasingly severe age- dependent cognitive dysfunction. How to reverse the loss of neurons for improving cognitive functions in elderly people and/or the aging population is an unmet goal. This study aims to develop an approach to enhance neurogenesis in the adult. Enhanced neurogenesis in the adult may replenish the lost neurons in AD patients, and reverse the course of neurodegenerative progression in the aging population. Hence, knowledge gained from this study has a high potential for developing drugs to treat early and late onset AD patients.